Pulmonary Immunopathology Core (PIP)

SUMMARY
The Center for Lung Biology and Disease (CLBD) at Louisiana State University (LSU) aims to elucidate the
molecular and cellular pathogenesis of life-threatening respiratory diseases, including those resulting from
infectious (bacterial, viral) and non-infectious stimuli (e.g., environmental, cigarette, e-cigarette aerosols). The
Pulmonary Immunopathology Core (PIPC) offers expertise and technical support for investigators in the COBRE
program. During Phase I, the PIPC provided equipment, facilities, and specialized training for COBRE Promising
Junior Investigators (PJIs; i.e., Research Project Leads) in pulmonary immunopathological techniques. The core
has already assisted six PJls, ten Pilot Project Investigators, and other NIH-funded investigators to successfully
pursue their research objectives resulting in high impact peer-reviewed publications and successful NIH funding.
The establishment of this core has facilitated productive collaboration among investigators and members of the
biomedical research community in Louisiana. This core has also educated underrepresented minority (URM)
undergraduate students, graduate students, postdoctoral fellows, summer scholars (DVM Students) in the
application of and the current advances in pulmonary immunology through lectures, laboratory classes, and
workshops. During Phase II, the PIPC will continue to meet two specific aims: Aim 1. To provide the COBRE
and other biomedical investigators with resources on comprehensive immunopathological assessments for mice,
including instrumentation, technical support and consultation. Aim 2. To educate faculty, staff, postdoctoral
fellows, and graduate students regarding the application and the current advances in immunopathological
assessments for mice. To ensure the success of the COBRE in Lung Biology and Disease COBRE PJIs, the
continued operation of the PIPC is essential to meet the current and future needs of LSU and other institutions
because this is the only PIPC in the state of Louisiana. In Phase II, the PIPC will provide required capabilities to
measure the immunopathological outcomes infectious and non-infectious inflammation in mice, will promote
immunological, pathological endpoints of project-specific parameters, and will streamline tasks to maximize
efficiency, productivity, benefits, and economy.